Targeting melanoma promoting RNA modification pathway for melanoma therapy.

PROJECT SUMMARY
Post-transcriptional mRNA modifications are central to establishing proteomic and functional diversity in
mammalian cells. These post-transcriptional mRNA modifications and their functional consequences are
controlled by RNA-binding proteins (RBPs). However, our understanding of these alterations and the role of
RBPs in melanoma metastasis is limited. Therefore, to identify RBPs that promote melanoma metastasis, we
performed a large-scale in vivo short-hairpin RNA screen by targeting 1500 human RBPs. Our in vivo screen
identified that YTHDF1, a reader of m6A modified RNA, is necessary for metastatic melanoma. The genetic
inhibition of YTHDF1 resulted in increased anoikis induction and enhanced NK cell-mediated metastatic
melanoma eradication. Additionally, an unbiased Photoactivable Ribonucleoside-Enhanced Crosslinking (PAR-
CLIP) analysis and follow-up studies identified IMPDH1, an enzyme of the de novo guanosine synthesis
pathway, and TrkB/BDNF that regulates Neurotrophin signaling pathway as potential downstream mediators of
YTHDF1-function in metastatic melanoma. IMPDH1 promoted anoikis resistance, while the TrkB/BDNF pathway
was necessary for suppressing NK cell-mediated cytotoxicity against melanoma cells. Our overall objective is to
determine the role of cell-intrinsic (anoikis resistance) and cell-extrinsic (NK cell-mediated anti-tumor immunity)
pathways in YTHDF1-driven melanoma metastasis and to establish pharmacological targeting of IMPDH1 and
TrkB/BDNF pathways as an approach for melanoma therapy. Aim 1 studies will determine the role of YTHDF1-
mediated anoikis resistance in driving melanoma metastasis and the role of IMPDH1 and the de novo guanosine
synthesis pathway in this process. Aim 2 studies will ascertain the role of YTHDF1-driven suppression of NK
cell-mediated anti-tumor immunity in promoting melanoma metastasis. We will also determine the role of
TrkB/BDNF pathway and its ability to inhibit the NKG2D activating ligand ULBP6 in suppressing NK-cell function
downstream of YTHDF1. Aim 3 studies will evaluate the therapeutic efficacy of TrkB/BDNF and IMPDH1
inhibitors either alone or in conjunction with other US FDA-approved metastatic melanoma therapies. Aims 1-3
studies will utilize complementary cell culture models based on established melanoma cell lines, short-term
patient-derived melanoma cultures and patient-derived xenografts (PDXs) of naïve and drug resistance
metastatic melanoma. The in vivo models for the proposed studies will include syngeneic, genetically engineered
mouse models of metastatic melanoma, spontaneous human melanoma metastasis model, and a highly
innovative immunocompetent humanized NSG-Tg(Hu-IL15) mice. These mice develop human NK cells in
addition to other immune cells after human hematopoietic stem cells transplant, which will allow us to perform
studies in the context of human NK cells. Collectively, these studies will uncover a novel YTHDF1-driven
melanoma metastasis pathway that can be targeted for treating naïve and drug-resistant metastatic melanoma.

Public health relevance
PUBLIC HEALTH SIGNIFICANCE Metastatic melanoma is the deadliest form of skin cancer that accounts for 8,000 deaths annually in the United States alone and currently approved therapies including BRAF/MEK targeted therapies and immune checkpoint blockade therapies benefit only a subset of metastatic melanoma patients. We have discovered that YTHDF1, a reader of m6A-modified mRNA, as a driver of melanoma metastasis and demonstrated that two downstream mediators of YTHDF1 function, the TrkB/BDNF and the metabolic enzyme IMPDH1, can be pharmacologically inhibited for metastatic melanoma therapy. Our proposed studies will establish YTHDF1 as a novel driver of melanoma metastasis, identify new mechanisms by which it facilitates melanoma metastasis, and ascertain the efficacy of small-molecule inhibitors of TrkB/BDNF and IMPDH1 for treating both naïve and drug resistant metastatic melanoma.